Assessment, Therapy and Prevention Of Autoimmune Disease

We are focusing on the idiopathic inflammatory myopathies (IIM), also known as the myositis syndromes, as prototypic autoimmune diseases from which principles learned in these disorders may be applied generally to other diseases. The myositis syndromes are associated with substantial lifelong morbidity and mortality. Their treatment is unsatisfactory in many cases and drug efficacy evaluation is hampered by the lack of reliable and standardized measures of disease outcome. Few therapies have been studied in randomized controlled clinical trials.

Because of the lack of consensus on how to best assess disease in the myositis syndromes, and to enhance recruitment of patients for other studies, new disease assessment tools are being developed and validated to apply to myositis in both adults and children. We have organized a multidisciplinary collaborative group of >600 adult and pediatric specialists with interest in myositis, known as the International Myositis Assessment and Clinical Studies Group (IMACS) to assist in this project. The goals of IMACS are to standardize the conduct and reporting of clinical studies in all forms of IIM. Achieving these goals should enhance the consistency by which clinical trials are performed, improve the capacity to compare different treatments, and encourage development of promising novel therapeutic agents. Therapeutic studies of novel biologic agents are in progress and others are being planned to utilize these outcome measures in prospective trials.

Together, and with input from the FDA and the European regulatory bodies, and with collaboration with Pediatric Rheumatology International Trials Organization (PRINTO), IMACS has: 1) developed and validated new tools to assess myositis disease activity and damage; 2) achieved consensus on core set outcome measures to comprehensively assess disease activity; 3) developed international consensus guidelines on details of the conduct of multi-center therapeutic trials for adult and juvenile IIM; 4) developed a clinical trial and outcomes data repository to allow us to reassess and revise IMACS tools; 5) developed new ACR-EULAR approved response criteria for polymyositis (PM) and dermatomyositis (DM) in adults and children that should result in more sensitive endpoints and fewer subjects needed for future clinical trials; and 6) in collaboration with other myositis researchers and consortia, have defined new classification criteria for adult and juvenile myositis which are provisionally approved by EULAR-ACR and should result in broader agreement on the inclusion of subjects in future clinical studies and trials. We have created a website to consolidate all IMACS activities, member lists, educational materials, presentations, assessment tools, and ongoing collaborative initiatives and studies (https://www.niehs.nih.gov/research/resources/imacs/index.cfm).

We developed response criteria for juvenile and adult DM and PM, using candidate response criteria derived from natural history data and a conjoint analysis survey. These were further validated using data from the PRINTO trial of prednisone alone compared to prednisone with methotrexate or cyclosporine and the Rituximab in Myositis trial. Consensus was reached for a conjoint analysis-based continuous model, using absolute per cent change in core set measures to determine minimal, moderate, and major improvement. The same criteria were chosen for adult DM/PM and JDM, with differing thresholds for improvement. These new response criteria had excellent performance characteristics in existing datasets and should be sensitive criteria that will provide a uniform approach for assessing treatment responses in future therapeutic and preventive clinical trials. These criteria are now approved by the American College of Rheumatology and European League Against Rheumatism. Work is ongoing to further validate these criteria.

Growing differences among specialties in how the IIM and their major subgroups are defined has led to difficulties in comparing new findings from multiple research studies. To address this, candidate variables were assembled from published criteria and expert opinion by consenus. Data were collected from 976 IIM patients and 624 non-IIM patients with mimicking conditions. New classification criteria for IIM with readily assessable measurements and symptoms have been developed that generally show superior performance compared with existing criteria. These criteria use a model system with differential weights for the clinical and laboratory variables, and a classification tree approach to the sub-classification of clinical subgroups of myositis. These criteria have been accepted by the American College of Rheumatology-European League Against Rheumatism, and have been endorsed by international rheumatology, dermatology, neurology, and pediatric groups. They employ easily accessible and operationally defined elements, and enable classification of "definite," "probable," and "possible" IIM, in addition to the major subgroups of IIM. These new classification criteria had excellent performance characteristics and should be sensitive criteria that will provide a uniform approach for assessing in future clinical studies of IIM patients. These criteria are now approved by the American College of Rheumatology and European League Against Rheumatism.

The therapy of myositis is focused on immunosuppression to minimize effects from immune activation and rehabilitation to improve remaining muscle function. Given the poor outcomes of myositis patients with standard therapy, novel biologic anti-inflammatory agents, which have been shown to be safe and effective for other immune-mediated diseases and have rationale for use in myositis, are reasonable candidates for study and may represent important advances in the treatment of myositis in the future. Our experience is that conducting therapeutic trials also greatly enhances recruitment to our epidemiologic investigations.

As part of the rituximab in myositis trial, we have identified changes in gene expression patterns in muscle and peripheral blood and the imaging features and immunopathology of muscle before (week 0) and after (week 16) therapy. Myeloid type I iIFN signature genes were expressed at higher levels at baseline in the skeletal muscle of rituximab responders than in non-responders, whereas classic non-myeloid IFN signature genes were expressed at higher levels in non-responders at baseline. Also, rituximab responders had a greater reduction of the myeloid and non-myeloid type I IFN signatures than non-responders. These findings suggest that high levels of myeloid type I IFN gene expression in skeletal muscle predict responses to rituximab in PM/DM and that rituximab responders also have a greater decrease in the expression of these genes. Further investigation of biologic predictors of response to therapy is ongoing.

We are currently evaluating treatment responses and factors associated with these for sodium thiosulfate as a novel therapy for moderate to severe calcinosis, and collaborated with investigators in NIAMS and George Washington University on treatment responses of JAK kinase inhibitors and abatacept therapy in patients with JDM. We have observed dramatic clinical improvement in treatment-refractory JDM patients following therapy with baricitinib (compassionate use pilot study) and tofacitinib (report of anti-MDA5 autoantibodies and interstitial lung disease), including documented improvement in muscle inflammation, skin, interstitial lung disease and calcinosis. Clinical improvements corresponded to pharmacodynamic biomarkers, including decrease in IFN gene score and stat phosphorylation of peripheral blood mononuclear cells.